BCM: Administrative Core

Project Summary Administrative Core The Administrative Core (AC) will be based at Baylor College of Medicine within the Department of Molecular and Human Genetics and the Rolanette and Berdon Lawrence Bone Disease Program of Texas. It serves an important role in integrating and facilitating the activities of the Program Project Grant (PPG). Given that the Program is distributed in three sites and methodological expertise for three prongs of the Approach are centered respectively at these sites, exchange and materials and resources is critical for success of the Program. As such the Administrative Core will have the following objectives 1) Establish and facilitate regular video teleconference meetings for all four research groups and for PIs. 2) Coordinate the shipment and transfer of human and mouse tissues. 3) Manage financial and track consortium agreements, and funds transfers as well as reporting. 4) Coordinate annual in person meetings of the PPG as well as ad hoc review committee and review of the program. 5) Facilitate communication and track interactions with collaborating infrastructure. A major strength and innovation of this PPG is its unique position as a nexus of multiple large NIH funded and other programs that can feed into the aims of the PPG.